Administrative Supplement to Support Summer Undergraduate Research for the Parent MIRA Award R35 GM141891 “Mechanistic Pharmacodynamic Modeling for Drug Combinations"

Project Abstract not applicable to NIH Supplement requests.

Public health relevance
Project Narrative not applicable to NIH Supplement requests.